Impact of prenatal inflammation on developing human brain

Project Summary
The materno-fetal interface is a crucial environment for a healthy fetal development during pregnancy
and delivery. A decrease in maternal trophic factors, such as maternal thyroid hormones or a maternal
inflammation/maternal immune activation (MIA) have been linked to an increased risk for neurodevelopmental
disorders, such as autism or preterm births. However, there has been no study to date to directly evaluate their
impact on human developing brain. To fill this gap of knowledge, we propose to experimentally study the
consequences of inflammatory factors on human neurodevelopment using the cerebral organoids co-cultured
with microglial cells, a 3D model that mimics the early stages of the human brain development. Microglial cells
are immune cells of the central nervous system that are generated in the yolk sac and penetrating the brain
parenchyma during a critical time of the embryogenesis coinciding with synaptogenesis and gliogenesis. Given
that microglial cells are generated in the periphery, we hypothesized that microglial cells are an important
component of the human brain development and most likely the first brain cell type to be exposed and respond
to an environmental factor/toxin that can potentially contribute to neurodevelopmental disorders prenatally.
Here, we will investigate the impact of maternal inflammation due to bacterial or viral infections on human
microglial cells and how that can impact the human developing brain. In addition, given that a person could be
exposed to more toxic factors simultaneously or sequentially during that individual’s lifespan or during pregnancy,
we will also aim to closely replicate the human experience, by testing the impact of co-exposures to infectious
agents and study their synergistic impact on human microglial function and human neurodevelopment.
Current studies using iPSCs has been limited sample size and the lack of diversity in the samples that
are often derived from donors from a single race/ethnical group. Thus, to have a more inclusive approach, in this
proposal, we will use a large cohort of samples from healthy individuals (>50), representative of different races,
ethnicities and genders closely mimicking the proportions found in the United States’ population that will provide
a better understanding of the health disparities and interventions both in populations and in specific subgroups.
Ultimately, our goal is to provide a better understanding of the disease mechanisms involved in maternal
inflammation and better targeted therapies from which the majority of the population in the US could benefit from.

Public health relevance
Project Narrative The proposal entitled “Impact of prenatal inflammation on developing human brain” will study the consequences of (co-) exposure to maternal inflammation due to bacterial or viral infections toxins on developing human neuroimmune system using human iPSC-derived cerebral organoids co-cultured with microglial cells. Studies using iPSCs have been limited in sample size and lacked diversity, often derived from a single race/ethnical group. Here, we will collect samples from a diverse ethnical and racial group of healthy individuals, representative of the proportions found in the U.S. population, that will help us better understand the health disparities and interventions both in populations and in specific subgroups, identifying new therapeutic targets leading to more efficient therapies from which the majority of the population in the US could benefit from.